StuDy AimED at Increasing AlCohol AbsTinEnce (DEDICATE)

PROJECT SUMMARY/ABSTRACT
The long-term objective of this award is to support Dr. Hagar Hallihan, an African American woman, in
advanced training in clinical research and neuroscience and establishing an independent research program.
Her research program focuses on developing clinically relevant and effective integrated behavioral
interventions to improve treatment efficacy and better understand the neuro mechanism of treatment for young
adults with alcohol use disorder (AUD). Her mentorship team is a transdisciplinary group of senior scientists
with research expertise in behavioral clinical trials, behavioral intervention development, AUD in young adults,
neuroimaging data, and quantitative and qualitative research methods. She will continue working with her
current T32 mentor, Dr. Ma, a senior scientist with extensive experience mentoring trainees. This will be
complemented by content and mentoring expertise from Drs. Ajilore, Rospenda, and Wu. Collectively, this
team will provide an outstanding training environment that will allow Dr. Hallihan to fill critical gaps in her
knowledge and skill set relating to the study of behavior interventions and neural mechanisms underlying
treatment for young adults with AUD. Her training goals are to develop skills in (1) designing and assessing
effectiveness of mechanistic randomized clinical trials, (2) competency in statistical and fMRI data analyses,
and (3) knowledge and skills in the neurobiology of alcohol addiction. In addition, she will develop professional
skills in scientific leadership and interdisciplinary team science. Achieving these goals will strengthen her
scholarly activities, establish important collaborations, and acquire critical data that will ensure her successful
transition to independence. The proposed research plan builds on Dr. Hallihan’s prior research training in AUD
among young adults. AUD, a chronic disease of impaired ability to stop or control alcohol use, is a costly major
public health problem, most prevalent in young adults (aged18-24 yr). Heavy alcohol consumption impairs
brain structure and function, more severely in young adults than in older adults. However, evidence-based
treatments for AUD in young adults are lacking, and the neural mechanisms following available behavior
treatments are poorly understood. The aims of the K99 phase are (1) to develop an integrated contingency
management (CM) and Problem-Solving Therapy (PST), CM-PST intervention to improve alcohol abstinence
among young adults with AUD, and (2) test feasibility and acceptability of the intervention. The aims of the R00
phase are to (1) test the efficacy of CM-PST vs CM alone in a 2-arm pilot RCT, and (2) assess neural
mechanisms associated with CM-PST treatment effects in young adults with AUD. Support from this award will
enable Dr. Hallihan to launch an independent program of research that contributes to the field by 1) developing
and implementing an innovative intervention to improve alcohol abstinence among young adults with AUD, and
2) assess neural mechanisms of successful treatment among young adults with AUD to inform future
intervention and prevention efforts and ultimately reduce the public health burden of AUD.

Public health relevance
PROJECT NARRATIVE Evidence-based treatments for Alcohol Use Disorder (AUD) in young adults are lacking, and the neural mechanisms associated with effective treatments are poorly understood. The proposed study will develop and test an integrated AUD randomized controlled trial intervention, among young adults, to improve treatment efficacy and inform about the neural mechanisms of treatment. Further, findings will help advance the development of future interventions to improve alcohol abstinence and ultimately reduce the number of young adults who develop AUD.